Emerging Infections Program (EIP)/PPACA: Enhancing Epidemiology and Laboratory Ca

DESCRIPTION (provided by applicant): The purpose of this project is to improve overall infectious disease surveillance capacity in Georgia by enhancing epidemiology and laboratory infrastructure in the currently-existing Georgia Emerging Infections Program (EIP), particularly in the areas of influenza testing, healthcare-associated infections, and expanding training opportunities in infectious disease epidemiology. The Emerging Infections Program (EIP) in Georgia is a continuing strong partnership between the Georgia Division of Public Health (DPH) and the Division of Infectious Diseases at Emory University School of Medicine and the Atlanta VA Medical Center. It is built on the foundation of an active population-based surveillance program in metropolitan Atlanta and throughout Georgia. Emory/VA EIP activities have focused on the 20-county greater metropolitan Atlanta area, while DPH EIP activities have focused on the other 139 counties (Georgia Outside of Atlanta, or GOA). Project activities include: 1) improving capacity for real- time reverse transcriptase polymerase chain reaction (rRT-PCR) influenza testing at the Georgia Public Health Laboratory;2) conducting active surveillance for dialysis access-associated bloodstream infections in the 8-County Atlanta metropolitan area;3) hiring an epidemiologist to support the nascent Georgia Healthcare-Associated Infections (HAI) Prevention Program;4) EIP partners will offer a one-year EIP Infectious Disease (ID) Fellowship Epidemiology/Public Health module during the third year of the ID training program at Emory University School of Medicine, including a several-month rotation in the DPH Epidemiology Program;and 5) coordinating a statewide Georgia EIP Educational Conference. Anticipated outcomes include: 1) improved completeness of EIP data in Georgia;2) improved timeliness of influenza testing at GPHL;3) improved capacity to characterize HAI epidemiology in Georgia, including risk factors associated with dialysis access-associated bloodstream infections;4) evidence base to better target HAI Program prevention activities in Georgia;5) improved partnerships with Infection Preventionists and other EIP stakeholders in Georgia.

Public health relevance
DEPARTMENT OF HEALTH AND HUMAN SERVICES Centers for Disease Control and Prevention Emerging Infections Program Patient Protection and Affordable Care Act (PPACA); Emerging Infections Program (EIP); Enhancing Epidemiology and Laboratory Capacity (U01) Funding Opportunity Announcement (FOA) Number: RFA-CI-10-003 Georgia Department of Community Health, Division of Public Health, Emory University School of Medicine, and the Atlanta VA Medical Center 1 Narrative/Research Plan Background and Understanding Georgia is one of the largest states east of the Mississippi River and has the country's ninth largest population. The U.S. Census Bureau estimates that Georgia's 2009 population was 9,829,211 and is projected to grow to almost 10 million during 2010. Since the 1990 Census, Georgia has moved from a largely rural state with urban clusters to an urban state with rural areas. Among Georgia's 159 counties, there are 14 urban counties, 29 urbanizing counties, 56 suburban counties, 30 rural growth counties, and 30 rural decline counties; counties fall into 15 metropolitan statistical areas (MSAs), five combined statistical areas, and 24 micropolitan statistical areas. Public Health service delivery is carried out by 159 County Boards of Health that are combined into 18 Health Districts, ranging from one to 16 counties. Each Health District is led by a physician Health Director. The County Boards of Health provide direct health care services, environmental health services, and work with community partners around issues of common concern, including disease surveillance and emergency preparedness. Each Health District employs at least one MPH-level epidemiologist. The Emerging Infections Program (EIP) in Georgia is a continuing strong partnership between the Georgia Division of Public Health (DPH) and the Division of Infectious Diseases at Emory University School of Medicine and the Atlanta VA Medical Center. It is built on the foundation of a successful active population-based surveillance program in metropolitan Atlanta and throughout Georgia. Emory/VA EIP activities have focused on the 20-county greater metropolitan Atlanta area, whereas DPH EIP activities have focused on the other 139 counties (Georgia Outside of Atlanta, or GOA). Drs. Farley (Emory/VA) and Drenzek (DPH) serve as Principal Investigators of the EIP program. Drs. Anil T. Mangla, Kathryn Arnold, Melissa Tobin-D'Angelo, Jessica Tuttle, Julie Gabel, Elizabeth Franko, Mahin Park, Tonia Parrott (DPH), and Drs. David Stephens, Susan Ray, Sarah Satola, and Jesse Jacob (Emory/VA), Lilly Immergluck (Morehouse), and Robert Jerris (Emory/CHOA) bring additional expertise as Co- Investigators or Collaborators in the EIP. Emory/VA investigators began conducting population-based active surveillance in the eight- county metropolitan Atlanta area (Health District 3, HD-3) for invasive pathogens including Haemophilus influenzae, meningococci, Listeria monocytogenes, and group B streptococci in 1988. Surveillance was expanded to include Streptococcus pneumoniae and group A streptococci in 1994 and foodborne pathogens in 1995. Georgia became the sixth CDC-funded EIP program in 1996 and ABCs surveillance was expanded to include the 20-county Atlanta metropolitan statistical area (MSA) in 1997. The MSA had a population of 5.2 million in 2008, more than half of the state population. The MSA surveillance area covers 51 participating institutions (29 acute care hospitals with labs, 10 acute care hospitals and five long-term acute care facilities that use other labs in the MSA, one acute care hospital that sends microbiology specimens to a lab outside the MSA, and seven reference labs). Using state and federal resources, the capacities of Georgia's Acute Disease Epidemiology Section (ADES), the Georgia Public Health Laboratory, and the Public Health Information 2 Technology Section of the Division of Public Health, Georgia Department of Community Health (DCH), have expanded substantially since the EIP began in 1996. Support from the EIP has been critical in this improvement. With EIP, Epidemiology and Laboratory Capacity (ELC), Public Health Emergency Preparedness (PHEP) and state support, the Acute Disease Epidemiology Section (ADES) staff has grown since 1996. The number of full-time epidemiologists at the state level has more than tripled and the number of state-supported epidemiologists at the District level has increased from zero in 1996 to 18 across the state now (one in each District). Anil T. Mangla, MS, PhD, MPH, FRIPH, Acting State Epidemiologist, devotes at least 35% of his time to infectious disease epidemiology. Five doctoral-level epidemiologists (including Dr. Cherie Drenzek, Director of the ADES), one doctoral-level medical entomologist, 15 MPH-level epidemiologists, four active surveillance officers, two program managers, and three part-time students share responsibility for epidemiologic activities in ADES. Over the past year, with ELC funding support for a staff Coordinator, ADES has expanded its activities to include the nascent Georgia Healthcare- Associated Infections (HAI) Prevention Program. Additional activities in the MSA include surveillance for invasive MRSA infections, laboratory- confirmed hospitalized influenza, Clostridium difficile infections (CDI) and candidemia. A number of case-control studies evaluating risk factors for foodborne and invasive bacterial infections and vaccine effectiveness (Hib conjugate, PCV-7, influenza, PCV-13) have been successfully completed or are currently underway. The EIP sites contributed significantly to understanding the 2009 H1N1 influenza pandemic by conducting active influenza surveillance, rapidly establishing surveillance for Guillain-Barre Syndrome and performing a H1N1 vaccine effectiveness study. The Georgia EIP is currently expanding activities in the area of healthcare- associated infections (HAI); DPH and the Emory/VA collaborators are working together to enhance participation in the National Healthcare Safety Network (NHSN), participate in a pilot project looking at HAI prevalence and to develop a protocol for multidrug resistant gram- negative rod infection surveillance. As of January 1, 2011, all hospitals participating in the Medicare program must report data on central-line associated bloodstream infections (CLABSI) through CDC's NHSN to avoid being subjected to a reduction in their Medicare Annual Payment. Patients on hemodialysis are at extremely high risk for healthcare-associated infections, in particular dialysis-access associated bloodstream infections (DAA-BSI). These infections are responsible for significant morbidity and mortality in this population and have been the focus of prevention efforts, largely targeting increasing the use of AV-fistulas for dialysis access in the place of tunneled catheters or grafts that are associated with higher rates of DAA-BSI. CMS regulations updated in April 2008 require all dialysis facilities to conduct surveillance for infections, with an emphasis on DAA-BSI. However, the surveillance methods and definitions are not specified. In 2009, the Centers for Medicare and Medicaid Services (CMS) introduced CROWNWeb, a web-based data collection system for Medicare-certified dialysis facilities throughout the United States. The system was designed to expedite the transfer of patient and facility data required by CMS including careful specification of the type of vascular access in current use for each dialysis session. The CROWNWeb system has been implemented in phases. Phase III (with 360 participating facilities) is planned for January 2011, with all Medicare- 3 certified dialysis facilities required to participate by spring of 2011. NHSN includes a DAA-BSI module. The NHSN system and CROWNWeb systems may be used together to enhance the ease of HAI surveillance and reporting. The Georgia EIP HAI Team has significant expertise in the area of dialysis-associated infections. Susan Ray, MD (Georgia EIP HAI PI) has more than 15 years experience as a hospital epidemiologist and in that role, developed a surveillance program for dialysis-access associated BSIs among the population of patients undergoing outpatient hemodialysis at the urban, indigent care hospital in which she is based. Nancy White, RN , CIC (Georgia EIP HAI Surveillance Coordinator) served as the Director of Infection Control at the same hospital for more than 15 years. In her role as Director, she worked in collaboration with the director of the hospital-based dialysis facility (20 stations with greater than three dialysis sessions per day) to improve compliance with CMS regulations and CDC guidelines for infection prevention including the conduct and reporting of hepatitis B and C surveillance. The Georgia Public Health Laboratory (GPHL) performs a full range of diagnostic tests to support public health programs and outbreak investigations. Annually, it receives more than 600,000 specimens for infectious disease testing. It performs pulsed field gel electrophoresis (PFGE) (now a vital component of surveillance and investigations) and is a member of PulseNet. GPHL's Decatur facility has the capacity (and extensive experience) to perform both real-time reverse transcriptase-polymerase chain reaction (rRT-PCR) and strain-specific virologic culture testing for influenza. In addition, the GPHL Waycross facility also can perform rRT-PCR influenza testing. Lab management runs from Dr. Elizabeth Franko, GPHL Director, to Drs. Mahin Park and Tonia Parrott, the microbiology lab supervisor and molecular biology supervisor, respectively. Solid and longstanding relationships are well established with infection preventionists, clinical microbiologists, and medical record departments in the Georgia surveillance institutions. All protocols are reviewed and approved or deemed exempt by IRBs and research oversight committees at CDC, Georgia DPH, Emory University, and the Atlanta VAMC. Individual IRB or research oversight committee approvals are obtained at individual institutions when required. The Georgia EIP has demonstrated the capacity to establish formal agreements with its academic partners (Emory/VA through the Atlanta Research and Education Foundation [AREF] and Morehouse School of Medicine [rotavirus project]) and with a community-based healthcare system (Kaiser-Permanente pertussis study). Georgia DPH is currently exploring an additional collaborative project with a private hospital system in suburban Atlanta exploring C. difficile transmission between acute care hospitals and long-term care facilities. Need Activity 1. Leadership and Coordination Emory/VA collaborators are currently taking the lead on 20 projects that are actively enrolling and require submission of approximately three to four IRB or research oversight committee submissions/renewals (e.g. Emory University and DPH IRBs, VA Research and Development Committee, and Grady Research Oversight Committee) per project each year. Seven additional projects with ongoing IRB approval are active but no longer enrolling. The Emory/VA collaborators are currently also responsible for five laboratory surveys, three healthcare 4 provider/institution surveys and providing oversight for two additional IRB approved projects being performed by subcontractors (rotavirus surveillance and pneumococcal carriage studies). Recent expansions in the areas of influenza, HAI, and C. difficile have challenged our capacity to provide scientific leadership and senior-level coordination for important new EIP projects. The Georgia EIP has a growing need for more participation by professional level investigators and additional coordination by staff members who can address the growing human resources demands, human investigations regulatory requirements, and grants management activities of the multifaceted EIP research program. Activity 2. Educational and Training Opportunities Related to Infectious Diseases Training Activities (DCH and Emory/VA Collaborators) The DPH/Emory Division of Infectious Diseases (ID) partnership enables Emory ID fellows to participate in EIP epidemiologic studies. The Emory Division of ID (Dr. Stephens is Director of the Division and former Director of the Master's in Clinical Research Training Program) offers a Postdoctoral ID Fellowship that uses Emory and CDC resources in epidemiology, basic or clinical research, and emerging pathogens. Thirteen current or former ID Fellows and Master's of Science in Clinical Research students and many other MPH students have participated in special projects related to the Emory/VA population-based EIP surveillance program. DPH staff train EIS Officers and Preventive Medicine Residents (PMRs) from CDC, Morehouse and Emory Schools of Medicine, and Emory Rollins School of Public Health (RSPH) students. EIP surveillance officers and trainees have prepared abstracts and presented data at local, regional, and national meetings. The Georgia Public Health Laboratory (GPHL) trains laboratory personnel from other institutions and provides a "state" lab experience for persons visiting or training in CDC labs. Georgia EIP projects provide training opportunities for EIS officers stationed in DPH and at CDC, Emory Rollins SPH MPH and doctoral students, infection control practitioners statewide, and disease investigators in local health departments. Funding pressures and the recent discontinuation of a CDC-funded ID fellow slot for epidemiology training in the Emory ID Division has undermined significantly the ability of ID fellows to participate in EIP activities. In 2010, Georgia EIP held its seventh annual full day conference for more than 220 infection control, laboratory, and District Health Office personnel; it included educational and training presentations by CDC, DPH, Emory faculty, and community partners in infection prevention, microbiology, and public health. The program included updates on national and local EIP surveillance, outbreak investigations in Georgia, EIP special projects, and other important emerging infectious diseases. This year, lunchtime concurrent sessions on HAI and clinical microbiology were added along with a poster session composed of recent EIP presentations at regional or national meetings. The response continues to be highly positive as the meeting fills an educational and training need as well as providing a venue for networking with our key contacts from throughout the state who voluntarily assist us with the EIP active surveillance system and special studies. Planning for the 2011 meeting is underway. Although we consider the annual meeting a wise investment in education and an essential component in enhancing the ongoing relationship with our partners, the cost of this meeting has increased over the years and is no longer covered by the budgeted EIP funds awarded. 5 The new CMS rule mandating reporting of CLABSI through the CDC NHSN network to avoid reductions in Medicare reimbursements presents a particular problem in Georgia. Only approximately 40% of hospitals in Georgia have enrolled in NHSN to date. There are immediate training needs to assist facilities with the enrollment process and to learn the definitions for the major body sites to be used for reporting. Equally important will be the need for ongoing training for new infection preventionists (IPs), since half of Georgia's hospitals have less than 100 beds and have only one IP. When turnover occurs, new IPs often have no background in navigating the NHSN reporting site. Activity 3. Information Technology Comprehensive electronic health information systems can enhance quality and safety of medical care, identify disease prevention needs and efficiently monitor the success of health interventions. Optimal use of the electronic health information for public health purposes presents many challenges such as interoperability of databases and the need for more sophisticated programming tools to "mine" the ever-growing content of large datasets. Electronic reporting of notifiable diseases using direct transfer of HL7 coded laboratory data requires interfacing with the State of Georgia State Electronic Notifiable Disease Surveillance System (SendSS). On a smaller scale, the EIP programs face challenges of interfacing with and merging data from vital records datasets for death validation studies, birth record searches for identifying controls, and admission and ICD-9 discharge datasets for various studies. Geocoding of influenza and other surveillance data is an area of increasing interest that will also strain existing IT capacity in the EIP. The EIP FoodNet reporting system in Georgia currently involves dual data entry into both the PHLIS database and the State SendSS system, an inefficient process that also increases the risk of data entry errors. Enhanced IT support is needed to optimize and customize SendSS to allow single entry of FoodNet data, and assures the completeness and quality of data for both EIP surveillance and public health reporting. Funds are also needed to train surveillance officers in the advanced use of SAS, Access, and other data analysis programs to enhance the value of the epidemiologic data collected in EIP activities. Activity 4a1. Influenza PCR Testing To support EIP and routine influenza surveillance in Georgia, GPHL's Decatur facility performs both real-time reverse transcriptase-polymerase chain reaction (rRT-PCR) and traditional virologic culture testing for influenza viruses. In addition, the GPHL Waycross facility can perform rRT-PCR influenza testing. During the 2009 H1N1 influenza pandemic, the pre- analytical specimen receiving and processing areas of GPHL required additional personnel to handle effectively the increased number of influenza specimens in a timely manner. GPHL needs additional funding for influenza rRT-PCR testing, including support for two Laboratory Aides as well as supplies, consumables, and reagents not provided through the Influenza Reagent Resource (IRR) of the American Type Culture Collection (ATCC) and CDC. Activity 4a2. Burden of Influenza Current EIP influenza surveillance for laboratory-confirmed, hospitalized influenza represents a small fraction of the total influenza burden of disease. During the 2009 H1N1 pandemic, Reed et al. constructed a probabilistic multiplier model to adjust laboratory-confirmed case counts based upon a number of factors such as the likelihood of seeking medical care, of obtaining an appropriate specimen, and subtype specific testing being performed. More complete estimates of 6 the burden of influenza disease are needed to measure accurately the impact on health systems and the public health infrastructure and to prepare for future influenza seasons. Activity 4b. Healthcare-Associated Infections There are 85 dialysis centers (providing in-center hemodialysis) in HD-3, comprising a total of 1579 hemodialysis stations. The majority of the dialysis facilities are for-profit. DaVita and Fresenius combined operate over 80% of the hemodialysis stations in HD-3 (42 DaVita facilities with a combined total of 792 hemodialysis stations and 27 Fresenius facilities with a combined total of 525 hemodialysis stations). The average number of stations per facility (for both Fresenius and Davita) is 19. An estimate of the number of patients at risk for infection in these facilities each month can be calculated because a single hemodialysis station may provide dialysis for two to six patients each month (based on whether one, two, or three dialysis sessions occur each day at the facility and knowing that an individual patient is generally dialyzed three days per week). Thus, at the 69 Davita and Fresenius facilities in HD-3, between 2600 and 8000 patients receive dialysis each month. Based on published rates of dialysis access associated bloodstream infections (average 1.8 per 100 patient months, [Tokars et al. 2002 Am J Infect Control]), we anticipate from 45 to 145 DAA-BSI to occur among patients at these combined facilities each month. Operational Plan Activity 1. Leadership and Coordination Emory/VA Collaborators: We propose to recruit an Assistant Professor in the Division of Infectious Diseases to provide scientific leadership for expanded activities in the area of HAI and influenza. They will commit 25% FTE to EIP activities, including participation on working groups for protocol development, conference calls for study monitoring, data analysis, manuscript preparation and review and grant preparation and attending Steering Group Meetings. The TBA physician candidate will preferably also have a MPH or MSCR degree or prior EIS or public health research experience. The individual will be recruited from among four new faculty members hired as of July 2010 and will begin work on projects in the Fall of 2010. A senior research coordinator (0.5 FTE) will be added to the EIP staff to work closely with Wendy Baughman (EIP Coordinator with 18 years experience with the surveillance program) and Suzanne Segler (FoodNet Coordinator with 13 years EIP experience). The job description will include IRB oversight, grants management, and human resources/performance evaluation responsibilities. The position will be advertised in the Fall 2010 with the goal of hiring before the end of calendar year 2010. The individual will track EIP performance, with attention to quality and efficiency as delineated in the "Measures of Effectiveness" section. DPH Proposal: Currently, Dr. Kate Arnold in ADES is responsible for oversight of all EIP Active Bacterial Core (ABCs), Influenza, and Healthcare-Associated Infections activities in Georgia Outside of Atlanta (GOA). Dr. Arnold coordinates enhanced statewide meningococcal surveillance, oversees state influenza surveillance and EIP influenza activities, coordinates the current EIP Group B Streptococcus Retrospective Study, and oversees the entire nascent Georgia HAI Prevention 7 Program. To assist Dr. Arnold and to enhance general epidemiologic capacity related to EIP work in ADES, we propose to hire an additional EIP epidemiologist that will primarily support the Georgia HAI Prevention Program. Currently, the majority of US states require (by law) reporting and public disclosure of HAI data, reflecting strong nationwide concern about HAIs and belief in their preventability. For some HAIs, longitudinal surveillance has documented disease reductions associated with this increased attention and visibility. Of note, only a few states have attempted to validate HAI surveillance data, and these states appear to have among the highest HAI rates, reinforcing a need for data standardization and validation. The recently passed U.S. Centers for Medicare and Medicaid Services (CMS) rule on the Hospital Inpatient Prospective Payment System (IPPS) FY 2011 is expected to accelerate the momentum toward reporting of selected HAIs to NHSN in all states; however, states like Georgia without reporting mandates may continue to have difficulty in accessing facility-level data because of fears over discoverability. Validating, interpreting, and responding to HAI data to meet reduction targets is dependent on the local capacity of states to track and validate infections and increase adherence to infection prevention recommendations among reporting facilities. In Georgia, we currently lack such capacity. A sustainable HAI surveillance system will require access to facility-level data and sustainable funding for epidemiologic oversight. The Division of Public Health, in collaboration with the Georgia Healthcare-Associated Infections Advisory Committee are working toward legislation that will address concerns of facilities regarding discoverability, and to encouraging facilities to train in NHSN definitions and methods. NHSN participation has expanded greatly during 2010 as a result of these efforts. As we strive to meet the goals of the HHS Action Plan via the Georgia HAI Prevention Plan, and particularly once facilities begin to share data at the state level, we will need to increase epidemiologic infrastructure dedicated to HAI surveillance. We have successfully hired a Georgia HAI Program Coordinator whose job responsibilities include plan implementation, facility recruitment, and training. However, as NHSN enrollment and reporting among Georgia hospitals increase, we will need to secure a dedicated epidemiologist to coordinate surveillance of HAIs reported through NHSN. The epidemiologist will be housed in the DPH Acute Disease Epidemiology Section and would, in collaboration with EIP partners in the MSA, conduct data analyses, characterize baseline HAI rates, validate HAI data, investigate HAI outbreaks if appropriate, assist infection prevention programs, and assess impact of local and statewide interventions over time (to ensure progress toward HHS Action Plan/Georgia HAI Prevention Plan prevention targets). The primary functions of the epidemiologist will be: 1) to serve as a state-level expert in the NHSN reporting system; 2) to oversee the NHSN Georgia Users' Group (G-SNUG); 3) to conduct analysis and reporting of aggregate or individual facility HAI data, and to compile and analyze data from Georgia facilities and generate reports according to the Georgia HAI Prevention Plan; 4) to assess baseline HAI rates and priority areas for targeted interventions; 5) to conduct NHSN data validation; 6) to assess trends in HAI disease rates over time for facilities enrolled in NHSN (relative to interventions implemented); and 7) to collaborate on EIP HAI studies in the MSA, including the hospital HAI point prevalence study, active surveillance for Clostridium difficile infections, and new dialysis center studies. The position will be advertised in the Fall 2010 with the goal of hiring before the end of calendar year 2010. 8 Activity 2: Educational and Training Opportunities Related to Infectious Diseases Emory/VA Collaborators: a. EIP Epidemiology Training Program: We propose to offer a one-year EIP Infectious Disease (ID) Fellowship Epidemiology/Public Health module during the third year of the ID training program at Emory University School of Medicine. One fellow would be selected per year. The program would include two months of training and field work at the State Health Department (DPH) under the guidance of the DPH EIP PI (Drenzek) and other EIP Investigators (e.g. Arnold, Tobin-D'Angelo), a one-month rotation at the Georgia Public Health Laboratory, and nine months working with Emory/VA EIP investigators and staff. The individual would be required to submit a proposal for a data analysis project using existing EIP surveillance, CCS, or other datasets as part of the application process. The individual would be provided with advanced SAS training or other relevant analytical methods training during the module. The fellow would be required to submit the analysis to a national meeting and to submit the work to a peer- reviewed journal upon completion of the module. The fellow would be assigned to one or more active EIP protocols and be expected to participate in any protocol development, working group or study monitoring conference calls and meetings for that project and participate in the day-to-day coordination of the local study activities, working closely with the EIP Coordinator and staff assigned to the study. b. EIP Annual Meeting: As stated in "Need," the cost of this highly successful education and training activity offered yearly to our voluntary EIP partners throughout the state of Georgia exceeds the funds approved in the EIP budget. Funds are requested in this application to supplement the cost for the 2011 meeting (scheduled for March 22, 2011 at the Emory Conference Center) and for the 2012 meeting (date TBA Spring 2012). The program for the 2010 meeting has been included in Appendix 7. Attendees are surveyed each year to ensure that meeting objectives are achieved and to solicit input on education and training needs for subsequent meetings. Attendees include infection preventionists, microbiology supervisors, and local and district Health Department personnel from throughout Georgia-221 attended in 2010 (not counting the speakers and approximately 26 EIP staff). c. To enhance the ability to monitor HAIs in Georgia hospitals and to fulfill upcoming CMS requirements for CLABSI reporting using the NHSN network, the Georgia EIP will provide training sessions on the NHSN enrollment and the CLABSI reporting process to hospitals in Georgia. Emory/VA Collaborators have developed an integrated information module on a flash drive that brings together the latest available NHSN resources in a user-friendly format to provide to IP personnel at hospitals preparing to enroll in NHSN. In addition, in partnership with DPH, we plan to enhance the opportunities for training by offering several NHSN training sessions in HD-3 in November and December 2010. EIP HAI staff will also disseminate information on CDC training webinars and serve as a resource for advising new NHSN participants. Nancy White, a highly-experienced infection preventionist and EIP HAI/NHSN Coordinator, will present information on NHSN and the new CMS rule at the Georgia Infection Preventionist Network meeting in October 2010. Funds are requested to increase Ms. White's FTE from 0.5 to 0.75 to organize the training activities. 9 Activity 3. Information Technology Emory/VA Collaborators Proposal: Funds are requested for hiring a 0.5 FTE information technology support person with a background in health information systems to provide support for merging data from vital records and ICD-9 databases with EIP data, enhancing direct electronic data transfers for surveillance purposes, geocoding projects and streamlining database use within the EIP site. This individual will work with a DPH counterpart to optimize the SendSS interface for MSA and GOA FoodNet data. In addition, the individual will work with IT counterparts at the Atlanta VA to strengthen administrative computing approvals, manage the complex array of software program installation and troubleshoot network and computer security issues, particularly with our offsite Grady offices. Additional funds are requested to provide advanced SAS training to four surveillance officers or ID fellows participating in the training module per year. Activity 4a1. Influenza PCR Testing DPH Collaborators: The Georgia Public Health Laboratory (GPHL) provides real-time reverse transcriptase- polymerase chain reaction (rRT-PCR) testing to support influenza surveillance in Georgia. During the 2009 H1N1 influenza pandemic, the pre-analytical specimen receiving and processing areas of GPHL required additional personnel to handle effectively the increased number of specimens in a timely manner. To address these needs, we are proposing the addition of two laboratory aide positions. These positions would be responsible for the processing, accessioning, and aliquoting of specimens received for influenza rRT-PCR. These positions would address an identified critical need in the influenza rRT-PCR testing process at GPHL. Since, for the 2010-2011 season, the Influenza Reagent Resource (IRR) of the American Type Culture Collection (ATCC) and CDC will continue to provide rRT-PCR primers and probes, extraction kits, enzyme kits, and plastics to qualified public health laboratories for influenza testing, we are requesting funding for laboratory consumables and supplies not provided through this mechanism. These supplies include microcentrifuge tubes, pipette tips, storage boxes, specimen racks, additional plastics, molecular grade water, dry ice for specimen shipping, personal protective equipment, and shipping containers needed for influenza rR...